Finding the optimal balance of immunotherapy efficacy and toxicity.

U01 Abstract
Despite extensive research into cancer immunotherapy, immune-related adverse events (irAE)
remain a critical and poorly understood issue. To address this critical need, we have assembled a
multidisciplinary research team with broad and relevant expertise. The co-PIs of this proposal have
expertise in cancer immunotherapy, immunology, assay development, and bioinformatics. Together, we
have assembled a cohort of ~400 cancer patients treated with ICI, collecting longitudinal treatment, efficacy,
and toxicity data, as well as blood samples at pre-treatment baseline, throughout therapy, and at time of
toxicity. In our real-world data set, over 10 percent of cases have a history of autoimmune disease,
providing insight into use of ICI in a population widely excluded from clinical trials yet routinely treated with
these therapies off protocol. Our high-quality clinical data annotation—without which correlative studies
have little meaning—addresses the reality that irAE may occur months after ICI initiation and are far more
complex to detect and characterize than toxicities of conventional chemotherapy or molecularly targeted
therapies. Through existing funding mechanisms, we have already completed autoantibody, cytokine,
genetic, and functional assays in these cases. However, we do not currently have resources for
comprehensive, integrated analysis of these diverse laboratory and clinical data. The overarching goal of
this U01 proposal is to determine the optimal balance between ICI efficacy and toxicity, ultimately
identifying a set of biomarkers useful for selection of patients, treatment type and duration, and
clinical monitoring. We will achieve this through determination of cellular immunity, comprehensive data
analysis, and clinical validation. We have three Aims: (1) Determine cellular immunity in patients
experiencing irAE and/or achieving beneficial responses from ICI. We will perform mass cytometry
(CyTOF) and T-cell receptor sequencing at multiple time-points. (2) Determine genetic, humoral, and
cellular factors associated with irAE and/or beneficial responses from ICI. We will develop a database
to integrate and analyze the CyTOF and T-cell receptor sequencing data with clinical efficacy and toxicity
data, as well as data from the assays already completed through other mechanisms. (3) Perform analytical
and clinical validation of emerging biomarkers. We will apply the best classifying phenotypes emerging
from our comprehensive and integrated data analysis to a test set of patients from our existing cohort,
eventually identifying a subset of biomarkers with potential for clinical application. Together, these Aims
directly address the FOA purpose of reducing the incidence and/or severity of irAE while retaining anti-
tumor efficacy.

Public health relevance
U01 Project Narrative Despite extensive research into and highly promising outcomes from cancer immunotherapy, immune-related adverse events remain unpredictable, potentially severe, possibly permanent, and—particularly with combination immunotherapy regimen—relatively common. Our proposed research will capitalize on our team’s years of experience in the genetic and molecular characterization of autoimmune diseases, as well as a previously assembled cohort of hundreds of patients treated with immune checkpoint inhibitor therapy for cancer, to perform, analyze, integrate, and validate biomarkers for the prediction of immune checkpoint inhibitor efficacy and toxicity. These findings may ultimately be used to guide patient selection, treatment, and monitoring, thereby impacting public health at a high level in both the near- and long-term.